Japanese People's Needs and Attitudes Toward Prenatal Ge

The purpose of this focus group study is to determine the adequacy of prenatal genetic counseling as practiced in the United States for people who have a Japanese cultural background, and to describe how genetic counselors can better address the needs and preferences of these people. The aims of the study are: 1. To assess what questions and needs Japanese People who are living in the US would have in a prenatal genetic counseling session, 2. To document the extent to which these people would feel comfortable talking about their emotions and psychological concerns in a genetic counseling session, 3. To describe how these people would make a decision about the pregnancy and prenatal diagnosis, 4. To document whether these needs and attitudes vary according to their degrees of acculturation.